Brain Oxygen Optimization in Severe Traumatic Brain Injury - Phase 3 (BOOST-3)

Traumatic brain injury (TBI) is a major cause of death and disability. Of the 3.5 million Americans who sustain a
TBI every year, approximately 27,000 experience prolonged traumatic coma, the most severe form of TBI.
Less than 20% of these patients make a good recovery, and most are left with life-long disabilities. ICU
management of severe TBI focuses on monitoring intracranial pressure (ICP), but data from recently
conducted randomized clinical trials indicate that this approach is overly simplistic. Another approach is to
monitor the partial pressure of oxygen in brain tissue (PbtO2) and apply interventions to prevent brain tissue
hypoxia and improve neurologic outcome. Clinical studies demonstrate that brain tissue hypoxia is common,
that there is a strong relationship between low PbtO2 and poor outcome, and that timely interventions can
reverse brain tissue hypoxia. The first randomized controlled trial of PbtO2 monitoring in severe TBI, titled
“Brain Oxygen Optimization in Severe TBI (BOOST) Phase 2,” enrolled 122 subjects and demonstrated that
the mean hypoxia burden was reduced by 74% by the treatment protocol informed by PbtO2 monitoring (p <
0.0001), and there were no significant safety issues. There was a trend towards improved functional outcome,
supporting the pre-determined non-futility hypothesis. We are proposing the BOOST-3 trial to determine if
there is evidence of clinical efficacy of a treatment protocol based on PbtO2 monitoring compared to treatment
based on ICP monitoring alone. BOOST-3 will enroll patients with severe TBI requiring placement of ICP
monitors within 6 hours of presentation to a participating hospital. Patients will be randomized to a treatment
protocol based on ICP monitoring alone or the combination of ICP and PbtO2 monitoring. The Glasgow
Outcome Scale-Extended (GOS-E) measured at 6 months post injury will be the primary outcome. Other
secondary outcomes include functional, cognitive and behavioral assessments at 6 months, safety, survival to
discharge, shortened time to follow commands, and reduction of total brain hypoxia exposure.

Public health relevance
Traumatic brain injury (TBI) is a major cause of death and disability in developed societies. Every year, approximately 3.5 million Americans sustain a TBI, of which 50,000 die, and another 300,000 are hospitalized and survive the injury. This proposed study focuses on the most severely injured of this group, approximately 27,000 Americans each year who experience prolonged coma from a TBI, and require sophisticated care in neurological Intensive Care Units. This group experiences high rates of mortality and morbidity, and only 20% make a good recovery resulting in an enormous psychosocial burden on patients, their families, and society. This study proposes to determine whether a treatment protocol based on brain tissue oxygen monitoring, using technology that has been available for over 10 years, improves neurologic outcome in this most severely injured group of patients.